Research Training in Physiological Adaptations to Stress

PROJECT SUMMARY
The primary goal of this training program entitled “Research Training in Physiological Adaptations
to Stress” (PAS) is to provide a new generation of future scientists with authentic interdisciplinary
training and educational experiences that emphasize a translational approach to understanding the
physiological mechanisms which mediate organismal stress adaptation. Key aspects of the new
PAS program include using the One Health interdisciplinary public health framework as a lens for
solving human health and disease problems, better integration of entrepreneurial principles to
develop a discovery mindset, and applying with fidelity principles of rigor and reproducibility.
Familiarity with opportunities and challenges posed by generative artificial intelligence is another
key innovation, which we view as a training imperative to prepare our trainees for the 21st century
workforce. Value added training in entrepreneurship using a boot camp approach, and team
process through the Penn State MBA program will facilitate discovery. Graduate students presently
encounter little formal training in regulatory science, and the inter-disciplinary curriculum we
propose will better prepare our students for emerging academic and nonacademic biomedical
careers. An understanding of the business, legal and regulatory issues which shape key milestones
in the biomedical science pathway, and the ability to work in diverse teams will allow our trainees
to be leaders of innovation. Here, rigorous research design and core competencies necessary for
effective communication are also emphasized. The training program takes advantage of existing
faculty biomedical expertise in four academic colleges who have amassed an impressive training
record while maintaining research excellence, with an overall time to the PhD of 5 years with little
attrition. We propose selection of 5 students per year for a period of two years (total of 24 trainees).
Additional institutional matching funds will allow for the training of 7.5 additional trainees. The
institutional commitment to our training program is outstanding. A foundational course entitled
“Physiological Adaptations to Stress” has been designed specifically for the training program, and
will serve as a capstone experience to emphasize program goals using multiple levels of scientific
inquiry (cells to human). Defining a new conceptual framework for hypothesis-driven research to
inform mechanisms of stress adaptation within a rich academic environment with dedicated
mentoring, strong research support and institutional commitment is proposed. We envision trainees
will continue to participate in program activities at the conclusion of their tenure as a T32 Fellow.

Public health relevance
PROJECT NARRATIVE The role of stress as the underlying cause for human adaptation is well-appreciated. Inherent in this response is the logical progression to human disease and disability, as there is little debate regarding the link between many different types of stress and the natural history of disease initiation and progression. The proposed program will focus on predoctoral scientist training in common themes of stress adaptation, and emphasize new core competencies that will develop new research skill sets, preparing scientists to innovate and discover novel therapeutic interventions.